Maximizing Hearing Recovery from Peri-Synaptic Damage

Principal Investigator: Hongzhe Li Program Summary
Project Title: Maximizing hearing recovery from peri-synaptic damage
Program Summary
Ototoxicants such as aminoglycoside antibiotics, and anti-neoplastic cisplatin, cause cytoplasmic
stress within the sensory hair cells and the spiral ganglion neurons, affecting synaptic functionalities and
signal transmission towards the central auditory system. We hypothesize that ototoxic cochlear synaptic
damage that to some extent resembles noise-induced synaptopathy, accounts for the observation that
after various ototoxic insults, within particular dosing range, without effective intervention, the auditory
functions deteriorate permanently, despite of minimal or no hair cell loss. Thus, in the present project,
we will investigate the similarity and discrepancy of synaptic damage due to noise or aminoglycosides
and decipher the cause of synaptopathy at cellular and molecular levels.
The proposed project is designed to investigate the aminoglycoside treatment conditions, which
result in classic synaptopathy, and to search for optimal therapeutic temporal windows and candidate
agents to intervene with degeneration process. In this manner, study findings will permit maximal hearing
recovery after either noise over-stimulation or exposure to ototoxic insults. The specific aims of this
project are to:
First, determine the optimal aminoglycoside dosage that produces maximal ototoxic synaptopathy
without functional hair cell damage in CBA/CaJ mice. An established 14-day gentamicin protocol will be
used, with various dosing strategy. Electrophysiological and acoustical measures, including auditory
brainstem responses (ABRs) and distortion product otoacoustic emissions (DPOAEs), will be used to
assess post-synaptic (ABR) and pre-synaptic (DPOAE) outer hair cell function, respectively.
Second, using the optimal gentamicin dosing, we will characterize the dynamic synaptic modification
in ototoxic synaptopathy. Here, we will conduct morphological investigation to visualize the synaptic
variation and the survival of spiral ganglion neurons at multiple time points after the initiation of
gentamicin treatment.
Third, we will determine the effects of cochlear inflammation on synaptic damage, using genetically
modified mouse models including Darc and TrpV1 knockout mice. Both strains of mice present certain
degree of resistance to noise-induced hearing loss.
Last, we will test potential audiologic rehabilitation strategies for synaptopathy, focusing on
inflammation suppressive corticosteroids. This is the major rehabilitation component of the project, we
will perform intratympanic injection of several therapeutics in the models of ototoxic and noise-induced
synaptopathy. Auditory function will be assessed by ABR and DPOAE at several post-treatment time
points, and synaptic element examined by immunolabeling and microscopy.
Cochlear synaptopathy plays an essential role in auditory damage, likely affecting the supra-
threshold auditory functions. These functions are critical for frequency selectivity and temporal
processing, both important for speech understanding and listening in the noise environment. This
creates an extreme adverse situation in military settings when effective interpersonal communication
means life-or-death, and greatly affects the life quality of Veterans. This research proposal is ultimately
to improve the effectiveness of rehabilitation from synaptic damage in the inner ear.

Public health relevance
Principal Investigator: Hongzhe Li Narrative Project Title: Maximizing hearing recovery from peri-synaptic damage Narrative Many Veterans suffer from noise-induced hearing loss (NIHL) due to exposure to high intensity sounds during their military service. Wounded soldiers and Veterans often receive critical lifesaving antibiotics to treat and prevent bacterial infections, which also put them at a high-risk for a drug-induced ototoxicity. Increasing evidences suggest substantial noise- and drug-induced hearing loss can include synaptopathy, which may be reversible, if treated on time. Thus, this type of neurological injuries has potentially significant implications for military Service Member performance, long-term received Veterans health, and noise exposure standards. The present study is designed to better understand cochlear synaptic damage and to investigate rehabilitative strategies to disrupt such neural degeneration. Study results will contribute to Veterans Health Administration’s (VHA’s) goal to help improve the quality of life of Veterans, who suffer from hearing loss due to noise damage and drug-induced ototoxicity.